Data Management and Analysis Core

Data Management Core Principal Investigator: Olivier Elemento, PhD. Co-I: Zhengming Chen, PhD Abstract This Core will provide bioinformatics expertise and support with data integration and analyses. The Core will serve three main goals. First, it will provide central data storage and data management ensuring that the integrity of the data of the Projects and Cores is protected using appropriate safeguards. Second, it will assure data and metadata sharing and dissemination through the ImmPort, database or other databases as recommended by NIAID. Third, it will support Projects 1 and 2, by performing state of the art statistical analyses. Specifically, the Core will be responsible for: 1) Deploying an informatics platform for data ingestion, processing and sharing using a cloud-based platform. The platform is capable of ingesting data from all participant sites and will interface with the clinical data based (REDCap) and sample tracking databases (OpenSpecimen) using appropriate safeguards. In addition, the Data Management Core will deploy automated quality control scripts to detect potential batch effects and low-quality samples. Importantly the core will use the ImmPort data model for data storage, thus standardizing data relations and facilitating data dissemination; 2) Perform statistical and integrative analyses of diverse datasets using state-of-the-art univariate and multivariate statistical as well as machine learning techniques. This approach will optimize the use of resources and will facilitate integration and synergy among all projects.